Genotype-Tissue-Protein: proteomic variation and quantitative trait loci (pQTL)

DESCRIPTION (provided by applicant): The goals of the proposed research are to systematically characterize proteomic variation in multiple human tissues and improve the annotation of the human genome. The mapping of gene expression quantitative traits (eQTL) using microarray or RNA-seq has provided a rich source of information for human biology and for interpreting genotype-disease association findings from genome-wide association studies (GWAS). In contrast, much less work has examined variation in protein sequence and abundance, and the genetic basis of proteomic variation remains largely unexplored. The objective of this research is to quantify the abundance of proteins and to catalog protein variants in at least five human tissues using an advanced quantitative mass-spectrometry-based platform. The three Specific Aims are to (1) Quantitatively measure protein abundance in 100 individuals across five tissues, (2) Characterize variation and functionally annotate the tissue-specific human translatome; and (3) Map genetic variation that influences protein abundance (pQTL). Mass spectrometry data will be used to verify previously predicted intergenic and intronic regions that encode protein, and to better annotate the translated region of the human genome. By preferentially selecting multi-tissue donors, this project maximizes the utilization of the GTEx resource and provides a unique opportunity for quantifying protein diversity and variation between individuals and across tissues. Proteomic variation represents a molecular phenotype downstream of RNA expression and may provide a critical link between RNA expression and phenotypes. We expect that the pQTL mapping analysis may capture post-transcriptional regulatory mechanisms that are not captured in eQTL mapping studies. Together, the new data generated in this research will have an important positive impact on biological and biomedical research, because they offer important clues for interpreting genotype-phenotype correlation identified through genome-wide association studies. They will also validate the annotation of the human transcriptome with regards to location of translation start sites, splice isoform diversity and heteroallele and editing expression. They will provide a rich resource for the human genome community. Ultimately, we expect the ensemble of molecular phenotypes and annotation will improve our ability for predicting an individual's disease susceptibility, as well as contribute to the design of individualized prevention and intervention strategies.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project will produce the first large-scale multi-tissue characterization of normal proteomic variation in humans. The data generated in this project will provide a valuable resource for understanding the genetic basis of complex traits; an understanding of normal proteomic variation will also facilitate research aims to discover disease biomarkers.